Treating early stage diabetic retinopathy

Diabetic Retinopathy (DR) is a leading cause of vision loss in the US. To detect DR, individuals with
diabetes are instructed to receive annual eye exams until visible retinopathy such as hemorrhages or
aneurysms appear that often take years to develop. Even so, treatment is only provided when visually
threatening disease is detected. Our group and others have established that in people with diabetes, retinal
neuronal dysfunction precedes clinically visible retinopathy. Non-invasive recordings of retinal function using
the electroretinogram (ERG) have shown dysfunction with diabetes, particularly in the oscillatory potentials
(OPs) that are generated by inner retinal neurons. A fundamental gap in our knowledge of DR pathology is
whether neuronal dysfunction is associated with or causal to the late stage vascular defects. Our overall
hypothesis is that neuronal defects precede vascular defects in DR and that treating neuronal deficits
early in DR will prevent late stage vascular defects that result in vision loss.
Dopamine, a key neuromodulator in the retina, is reduced in DR. We demonstrated that treating rodent
models of diabetes with levodopa, a dopamine precursor, is neuroprotective for neuronal dysfunction.
Importantly, we also showed that in patients with diabetes and retinal dysfunction, but without retinopathy,
levodopa taken for only 2 weeks restored retinal dysfunction to normal levels. Thus, our preliminary data
suggest that earlier screening and treatment are possible to prevent or delay retinal dysfunction in early DR.
Since current clinical management of DR is directed at more advanced stages of disease when vascular
defects are present, it is critical to determine if levodopa will also prevent vascular pathology.
We propose the following specific aims to investigate the link between neuronal and vascular defects in
DR by using neuronal (dim flash ERG) and vascular (fundus photography and optical coherence tomography
angiography) primary outcome measures:
Aim 1: Investigate whether the appearance of early neuronal dysfunction predicts late stage
vascular pathology in diabetes. We propose follow-up testing on a cohort of participants with diabetes, and
normal or delayed OPs, from a prior clinical study to determine how many develop signs of retinal vascular
defects after 3-5 years.
Aim 2: Determine whether levodopa treatment initiated at detection of retinal dysfunction will
prevent retinal dysfunction and vascular defects. We will conduct a randomized clinical trial with levodopa
versus placebo using participants with diabetes and confirmed OP delays from two groups: 1) without
retinopathy and 2) with the earliest signs of DR (microaneurysms). Patients will receive levodopa or placebo
twice daily for 6- or 24-months. For the 6-month duration, testing will be done at baseline, 3 months and 6
months. Patients will then return to routine standard of care and be re-tested at 12 and 24 months. For the 24-
month duration, testing will be done at baseline and every 3 months until 24 months. Participants will be
carefully monitored for levodopa side effects with the assistance of a neurologist.
Determining the association between neuronal and vascular defects in DR is critical to shifting clinical
practice toward early diagnostic markers, a move that could transform the way DR is monitored and treated,
ultimately leading to better preservation of normal visual function.

Public health relevance
Diabetic Retinopathy (DR) is a leading cause of vision loss in the US. Individuals with diabetes are instructed to receive annual eye exams until visible vascular changes appear which take 10-15 years to develop. The established premise that DR is only a microvascular disease, as clinically defined, has been challenged in recent years by evidence that retinal neurons undergo changes in function and structure prior to the vascular pathology. A fundamental gap in our knowledge of DR pathology is whether neuronal dysfunction is associated with or causal to the late stage vascular defects. The proposed experiments in Veterans with diabetes are designed to elucidate if neuronal defects precede vascular defects in DR and if treating neuronal deficits with levodopa early in DR will prevent the late-stage vascular defects that result in vision loss. The proposed work will inform the clinical management of DR and potentially shift detection and treatment earlier to prevent vision loss.